PATTERNS OF ALCOHOL INVOLVEMENT AMONG MEXICAN AMERICANS

The proposed research will contribute to an understanding of the patterns of alcohol use and alcohol disorder among Mexican Americans. The analyses will focus on differences in patterns as a function of ethnicity (Mexican Americans compared to nonhispanic whites in the same region), and among Mexican Americans, as a function of country of birth (immigrant versus native-born), acculturation, urbanicity, and region. The proposed study will analyze data available from two recent studies which surveyed large probability samples drawn from adult household populations of Mexican Americans: The Los Angeles Epidemiologic Catchment Area (LAECA) study, and the Hispanic Health and Nutrition Examination Survey (H-HANES). The specific aims of the analyses will be: 1) To describe patterns of alcohol consumption as a function of ethnicity, and among Mexican Americans, as a function of immigrant status, acculturation, urbanicity and region; 2) To determine the relationship of alcohol consumption and alcohol disorder among Mexican American immigrants and natives, and nonhispanic whites; 3) To estimate changes in alcohol consumption assessed prospectively over one year, and the relationship of changes to past and current alcohol disorder, among Mexican American immigrants and natives, and nonhispanic whites; 4) To examine the impact of alcohol consumption on social, role, and physical functioning among Mexican American immigrants and natives, and nonhispanic whites; 5) To determine the impact of alcohol consumption on utilization of health services among Mexican American immigrants and natives, and nonhispanic whites; 6) To examine the relationship of alcohol consumption to depression among Mexican American immigrants and natives, and nonhispanic whites; 7) To describe the natural history of alcohol disorder, retrospectively, among Mexican American immigrants and natives, and nonhispanic whites.